METEOR Administrative Core

ADMINISTRATIVE CORE SUMMARY
Critical to the success of the Washington University (WU) ROBIN “MicroEnvironment Tumor Effects Of
Radiotherapy” (METEOR) Center is a structured approach to overall integration and coordination of Center
components and strategies while simultaneously ensuring synergy within the overall NCI ROBIN network. The
Administrative Core (Admin Core) will tie together the (1) Molecular Characterization Trial (“Comprehensive
Radiotherapy Assessment TRial” (METEOR-CRATR)), (2) Research Projects (Project 1 – Cervical cancer (P1-
Cervix), Project 2 – Pancreas cancer (P2-Panc)), (3) Shared Resource Cores (SRCs) for omics and data
management (“BioLogical Specimen Translation” (METEOR-BLST), “Data Synthesis and Transfer” (METEOR-
DST)), and (4) Cross-Training Core (“Integrated Training Environment” (METEORITE)). The Admin Core will
also be responsible for management of key initiatives critical to enable short- and long-term success of the
METEOR Center and the core tenants of the ROBIN Network. The Admin Core will integrate METEOR Center
components through the Admin Core to optimize communication and synergy through a modified hub-and-
spoke model with regimented meetings and centrally managed digital collaboration tools and enable a
structured approach to iteration and refinement of METEOR Center activities through routine engagement with
leaders during meetings. The Admin Core will also operationalize the trans-ROBIN pilot project process and
create ongoing opportunities to expand the impact of discovery within the Center through development of trials
and technology, and expansion of an evolving multi-disciplinary workforce through regular engagement with
WU resources committed to technology and discovery, close integration with METEORITE, and improving
awareness within and outside the Network.